COG Biospecimen Bank to Support NCI NCTN (U24)

Project Summary
The Children’s Oncology Group (COG) is the pediatric clinical trials group of the National Clinical Trials
Network (NCTN). Over 90% of United States and Canadian children and adolescents with cancer are
treated at COG institutions with no racial, ethnic or geographic bias to registration, allowing for near-
population-based clinical, translational and basic research. COG has established a strong track record of
collecting and banking tumor and non-diseased biospecimens from patients enrolled in COG-sponsored
clinical trials, most of which include randomized treatment questions. The COG Biospecimen Bank (COG
Biobank), located within the Biopathology Center (part of the Abigail Wexner Research Institute at
Nationwide Children’s Hospital), aims to provide high-quality pediatric and adolescent human malignant
biospecimens to the research community. Upon review and approval, biospecimens are prioritized for
distribution to the COG investigators defined in the clinical trial protocols. After the needs of the planned
research have been addressed, residual (legacy) banked biospecimens can be distributed to other
investigators within and outside COG via the NCTN Navigator The COG Group and Biobank Concierges
can also facilitate access to COG legacy biospecimens that are not currently uploaded in Navigator. For
all biospecimen distribution projects, a feasibility assessment by the COG Biobank and the COG
Statistical and Data Management Center (SDMC) is completed prior to proposal submission. This
proposal supports the collection, processing, and distribution of biospecimens from patient enrolled on
COG-sponsored trials. The Pediatric Division of the Cooperative Human Tissue Network (CHTN) then
facilitates the distribution of the approved legacy biospecimens.
The COG Biobank seeks to directly promote and support outstanding research in the diagnosis and
treatment of pediatric cancer through centralized collection, quality control, storage, and distribution
procedures. The COG Biobank will continue efforts to provide the latest biorepository-based
technological innovations and best practices, resulting in constant improvements in our operational
capabilities, investigator access to biospecimens, investigator satisfaction, and the stewardship of these
precious resources. Under proper regulatory guidelines and in association with the COG SDMC, the
COG Biobank will support translational aspects of cutting-edge research by ensuring appropriate tracking
of biospecimens as well as linkage to existing demographic, clinical, biological, treatment, and outcome
data. Finally, the COG Biobank will provide investigators with a comprehensive database solution and
dynamic informatics tools that facilitate pediatric cancer research. The COG Biobank also plans to
support the processing, banking, and distribution of biospecimens to the Cancer Immune Monitoring and
Analysis Centers (CIMACs).

Public health relevance
Project Narrative Cure rates for pediatric cancer have improved significantly over the past 30 years due to the enrollment of nearly all affected children in the United States on Children's Oncology Group (COG) clinical trials, and the research completed using biospecimens banked from these studies. The COG Biospecimen Bank aims to support additional pediatric and adolescent cancer research by collecting, processing, and distributing high quality biospecimens.